Mechanisms of cellular respiration-dependent cell lysis and its impact on biofilm formation and disassembly in Staphylococcus aureus.

The objectives of this proposal are to determine a) the factors and mechanisms that modulate biofilm formation
and dispersal as a function of cellular respiration in Staphylococcus aureus, b) determine how the expression
of these factors is regulated, and c) determine the molecular stimuli for a regulatory system that responds to
alterations in the cellular respiratory status. Staphylococcus aureus is a human commensal and a leading
cause of hospital and community acquired infections. For S. aureus to colonize and invade host tissues, it must
successfully sense and respond to environmental perturbations and transition between individualistic and
multicellular behaviors. S. aureus has the ability to form multicellular communities called biofilms, which are the
etiologic agents of recurrent staphylococcal infections. We have found that S. aureus modulates biofilm
formation as a function of electron flux though respiratory pathways. We have found that when S. aureus is
growing without a terminal electron acceptor (fermentative growth) there is an increase in cell lysis, which
leads to the release of intracellular components including DNA. The DNA that is released is vital to biofilm
integrity where it aids in holding the cells together in the biofilm matrix. We also discovered that the addition of
a terminal electron acceptor to fermentative biofilms resulted in biofilm dispersal. We have identified two global
regulatory systems that mediate fermentative biofilm formation. Both of these regulatory systems have been
shown to be necessary for pathogenesis, but their molecular stimuli are currently unknown. The overarching
goal of this project is to understand the physiological changes that occur within S. aureus upon changes in
cellular respiration, and examine how these changes affect the community structure. We will use genetic,
physiologic, biochemical, and molecular techniques to investigate an understudied variable that causes S.
aureus to modulate cell lysis, and thereby affect biofilm formation and biofilm dispersal. We will further define
the factors involved in fermentative cell lysis and biofilm formation. We will also define the factors and
molecular mechanisms involved in the dispersal of fermentative biofilms. We will examine the molecular stimuli
of one regulatory system (Sae) and examine how another regulatory system (Srr) controls the expression of
factors that alter cell lysis and biofilm formation. Ultimately, we would like to apply our findings to modulate the
behavior of S. aureus using molecules that alter cell signaling, and thereby, positively affect infection
outcomes. Completion of the studies will help provide knowledge about two requirements for staphylococcal
pathogenesis: environmental sensing and biofilm formation.

Public health relevance
Staphylococcus aureus is a human commensal and a major cause of hospital and community acquired infections. For S. aureus to colonize and invade host tissues, it must successfully respond to environmental perturbations and transition between individualistic and multicellular behaviors. The proposed work will investigate the mechanisms of respiration-dependent biofilm formation and dispersal, as well as the molecular stimuli and genetic regulatory components that signal for changes in multicellular behavior.